Data Sciences Core

CORE B- Abstract
The Data Sciences Core (Core B) will provide professional expertise in statistics, bioinformatics, and
computing to all projects, cores, and investigators in this “Thymic and peripheral aspects of T cell aging and
rejuvenation” Program Project (Program). Core B will provide biostatistics design and analysis for all mouse
and in vitro studies across Program, including formulation of testable hypotheses, estimation of sample size
and power, performance and interpretation of data analyses, and graphical display and interpretation of results.
In addition, the core will provide bioinformatics expertise and analysis for the the scRNA-Seq profiling
experiments in P1 – P3 and Core C. This support will include data quality checks, read mapping and
normalization, differential expression analysis, and pathway analysis to identify subsets of cells impacting
specific functions or cellular mechanisms. Core B statistical scientists make extensive use of modern methods
of statistical computing and reproducible research tools. This capability fosters the sharing of analysis code
and results, the rapid deployment of novel analysis tools, and effective investigator access to program-wide
data and knowledge management platforms for cross-project research discovery. Core B is a vital component
of each Project and will facilitate the discovery of novel scientific results in immune aging.